eNamptorTM: A Humanized mAb To Reduce the Severity of Radiation Pneumonitis and Fibrosis

ABSTRACT
The development of radiation-induced lung injury (RILI) is a potentially fatal toxicity in cancer patients
undergoing thoracic radiotherapy or in individuals exposed to ionizing radiation (IR) from a nuclear incident. The
pathobiology of radiation pneumonitis and radiation-induced lung fibrosis (RILF) is complex but includes the
deleterious effects of unchecked inflammation (reactive oxygen species, cytokines, inflammatory cells) that
increase vascular permeability, impair gas transfer and promote fibrosis. Although Toll-like receptors (TLRs) and
cytokines are potential therapeutic targets for reducing RILI, experimental and clinical strategies to neutralize IR-
induced proinflammatory cytokine effects or to block inflammatory cell infiltration have been disappointing. The
standard of care, high dose corticosteroids, remains controversial due to long term complications and frequent,
potentially fatal relapses. Thus, there is an unmet need to identify novel RILI therapeutic targets and effective
therapeutic anti-inflammatory strategies. Our preclinical studies utilizing whole lung thoracic irradiation (WTLI),
identified a cytozyme, nicotinamide phosphoribosyltransferase (NAMPT), as a novel RILI therapeutic target.
NAMPT exists as both an intracellular enzyme (iNAMPT) catalyzing nicotinamide adenine dinucleotide (NAD)
synthesis and as an extracellular inflammatory cytokine (eNAMPT). We have shown that eNAMPT is a damage-
associated molecular pattern protein (DAMP) and a ligand for TLR4 to potently induce the dysregulated
inflammatory response that results in cytokine storm, organ dysfunction, and death in severe critical illnesses.
We have also shown that NAMPT expression and secretion is markedly increased by radiation and is a key
contributor to RILI development and severity as NAMPT heterozygous mice exhibit reduced WTLI-induced RILI.
Furthermore, a polyclonal eNAMPT pAb effectively reduces WTLI-induced pneumonitis and fibrosis. We have
developed eNamptorTM, an effective eNAMPT-neutralizing humanized mAb that is now in stable cell line
development. This STTR Fast Track Phase I/II application seeks to confirm that eNamptorTM is a novel
therapeutic strategy in preclinical models of WTLI and PBI/BM5 (partial body irradiation, 5% bone marrow
sparing). We speculate that eNamptorTM will surpass the protection observed in mice receiving high dose
corticosteroids, thereby addressing a serious unmet need to reduce the risk and severity of RILI following IR
exposure. Aqualung Therapeutics (ALT), an early stage biotechnology start-up, in collaboration with its
academic partner (Univ. of Arizona) has assembled a highly skilled multidisciplinary team to evaluate
eNamptorTM as a therapeutic strategy in preclinical murine models of WTLI (SA #1) and PBI/BM5 (SA #2). We
will also assess the utility of a radiolabeled-NAMPT mAb probe, ProNAmptorTM, as a companion diagnostic
strategy that defines organ-specific sites of IR-induced NAMPT expression. STTR Phase II studies will profile
the pharmacodynamic (PD) and pharmacokinetic (PK) (SA #4) and toxicological characteristics of eNamptorTM
mAb (SA #5). The proof of concept of eNamptorTM’s utility in RILI will lead to a successful FDA IND application.

Public health relevance
NARRATIVE Radiation-induced lung injury (RILI) is a serious lung toxicity of ionizing radiation in patients receiving radiotherapy (for a variety of cancers) with radiation-induced pneumonitis and fibrosis both potentially lethal outcomes. Current therapies for RILI are extremely limited with only high dose corticosteroids utilized as a controversial treatment with limited efficacy at best and with serious toxicities. We have identified eNAMPT as a novel therapeutic target for RILI given its capacity to potently induce lung and systemic inflammation and generated, eNamptorTM, the eNAMPT-neutralizing, humanized monoclonal antibody, as a therapeutic strategy for treat RILI by reducing cytokine storm, organ dysfunction and potentially morbidity and lethality of ionizing radiation exposure. This STTR Phase I/II application is designed to evaluate eNamptorTM in RILI.